Phase 2 Study of Magnesium Supplements in the Treatment of PXE

DESCRIPTION (provided by applicant): The goal of this project is to assess the efficacy of magnesium oxide on the reversal of elastic fiber calcification and clinical lesions of PXE. To achieve this goal, this proposal outlines three specific aims. (1) The primary endpoint is to assess the reversal of elastic fiber calcification through skin biopsies. A blinded dermatopathologist will grade skin biopsies on the density of Von Kossa staining. The amount of calcification of elastic fibers will be determined by assessing von Kossa staining per unit area of dermis. (2) The secondary endpoint is to assess the reversal of clinical skin lesions through investigator evaluation and clinical photographs. (3) The final aim is to assess the rate of disease progression through ophthalmologic examinations. The study consists of two parts. The first part is a year-long, double-blind, placebo-controlled study. Part two is an open-label, year-long study. In Part 1, qualified subjects will be randomized to receive either magnesium oxide supplements, or placebo, in a 1:1 ratio for the first 12 months. The starting dose will be 1000 mg daily, and depending on tolerability, doses will be decreased. Baseline evaluations will be comprised of blood chemistry panel, serum magnesium, calcium and phosphorus levels, complete blood count testing, urinalysis, clinical evaluations, punch biopsy of target lesion, ophthalmologic evaluations, photographs of skin lesions, electrocardiogram, and bone densitometry. Upon completion of the first year, barring any safety concerns, all subjects will be administered magnesium supplements for up to one additional year. The same evaluations/procedures will be conducted during Part 2.

Public health relevance
PROJECT NARRATIVE Pseudoxanthoma elasticum (PXE) is a systemic connective tissue disorder involving elastic tissue calcification affecting the skin, ocular system (often leading to retinal bleeding and loss of vision), and cardiovascular system (accelerated heart disease, cardiac valvular disease, claudication, and gastrointestinal bleeding as a result of calcification in the arteries).1 Finding a modality of therapy that may reduce this calcification would be a substantial contribution to the clinical management of these patients and would ultimately improve their quality of life. __SpecificAimsTextDelimiter__ Specific Aims The goal of this project is to assess the efficacy of magnesium oxide on the reversal of elastic fiber calcification and clinical lesions of PXE. To achieve this goal, this proposal outlines the following specific aims: 1. Our primary endpoint is to assess the reversal of elastic fiber calcification through skin biopsies. A blinded dermatopathologist will grade skin biopsies on the density of Von Kossa staining. We will assess the amount of calcification of elastic fibers by assessing von Kossa staining per unit area of dermis. 2. Our secondary endpoint is to assess the reversal of clinical skin lesions through investigator evaluation and clinical photographs. 3. Our last aim of the research is assess the rate of disease progression through ophthalmologic examinations. Presently, there is no specific treatment that addresses the calcification that occurs in PXE. Finding a modality of therapy that may reduce this calcification would be a substantial contribution to the clinical management of these patients.